Ecopathogenomics of sexually transmitted infections (EPSTI)

DESCRIPTION (provided by applicant): In the battleground of an infection site, both the host cells and the microbes employ complex signaling mechanisms and weaponry to destabilize, neutralize or kill the other. Identifying and understanding these biomarkers of infection and disease are the short and long-term research goals of this Cooperative Research Center (CRC). The anticipated impact will be to reduce the incidence of sexually transmitted infections and diseases (STIs & STDs) in humans worldwide. This is a large scale challenge: in the United States, Chlamydia trachomatis (CT) genital infections are the most frequently reported bacterial infectious disease with an estimated 2.8M cases yearly. Likewise there are an estimated 820,000 cases of Neisseria gonorrhoeae (GC) each year. The sequelae of infections and co-infections caused by these two pathogens are insidious and account for the majority of the 750,000 annual cases of pelvic inflammatory disease (PID) in the United States, a precursor to life-threatening ectopic pregnancy and tubal factor infertility (TFI) in women. Thus, research to prevent, control and treat these STIs will provide broad health and economic benefits. We hypothesize that: a) the genetic variance of the infected host, the genetic diversity of the infecting pathogen(s), and the composition and function of the resident microbiota directly impact the evolution of STIs and could be biomarkers of disease severity or protection from STIs; b) genes, RNAs and proteins that are expressed or produced by the host, the pathogens, and/or the genital microbiota in response to one another are biomarkers of a specific type of STI or STD. The aim of the CRC is therefore to identify host, pathogen and/or microbiota biomarkers of STIs that may reveal mechanisms of pathogenesis and therapeutic or diagnostic targets that can be exploited for the development of translational curative or prophylactic interventions that have a direct impact in public health. To test these hypotheses and realize these objectives, this CRC, Eco-Pathogenomics of Sexually Transmitted Infections (EPSTI), will build on data acquired by the parent CRC, Eco-Pathogenomics of Chlamydial Reproductive Tract Infection, a Chlamydia-centric program that laid the methodological and conceptual foundations of EPSTI. Within EPSTI, STING (STI Network Groups), consisting of multiple networks of sexual partners, will be leveraged to examine the triangular relationship between human genetic variance, CT, GC infections and co-infections, and microbiota composition among partners with distinct infection outcomes. The experimental approach will essentially be a systems biology strategy focused on the identification of biomarkers of genital/reproductive infection and disease and are eminently amenable to translational applications in clinical and public health. These are expected to include predictive diagnosis for individuals at greatest risk of STI and STD based on their biological and microbiome characteristics, development of sensitive and specific point-of-care diagnostic tests and highly specific targets for vaccine development.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Program aims to provide the fundamental knowledge needed to develop improved diagnostic methods, identify novel targets for new drug development and develop targeted and effective curative or preventive therapies. This research is relevant to the NIH mission as it ultimately aims at promoting health, reducing risk to unintended adverse sequelae of sexually transmitted disease (STI) and improving the quality of life for men and women who are at risk of STIs.